NATIVE ENGAGEMENT AND PARTNERSHIP CORE

NATIVE ENGAGEMENT AND PARTNERSHIP CORE: PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease and related dementias (ADRD) research in the US is limited by underrepresentation of racial
and ethnic minorities. In particular, for decades American Indian and Alaska Native (AI/AN) people were nearly
absent from any ADRD research, so that today very little is known about ADRD prevalence, risk or protective
factors, or perceptions in this culturally and sociodemographically unique population. The NIH and other
organizations are actively calling for ADRD clinical trials to increase representation of AI/AN people and other
historically underrepresented groups, but investigators attempting to meet this need often struggle to achieve
recruitment goals. Accordingly, there is a need for studies to identify best practices for increasing the recruitment
of AI/AN people in ADRD research. Partnerships with AI/AN communities are challenged by distrust of scientific
research, misunderstandings, or competing priorities between researchers and communities. These sentiments
have led to widespread reluctance to engage in research, especially when biospecimens such as blood or
genetic material are collected for unspecified “future use.” No evidence-based methods exist that are proven to
increase AI/AN recruitment into ADRD clinical trials, including those where biospecimens are collected. Led by
Indigenous members of Washington State University’s (WSU) Institute for Research and Education to Advance
Community Health (IREACH), the Native Engagement and Partnership Core (NEPC) of the University of
Washington Alzheimer’s Disease Research Center (UW ADRC) will address these gaps and needs. Through
their ongoing ADRD-focused research efforts, NEPC investigators have been essential in building a large
network of relationships with AI/AN communities. They will further leverage IREACH’s strong relationships with
community partners in Washington state and elsewhere to ensure the inclusion of a meaningful sample of AI/AN
Elders in the UW ADRC’s efforts. Our Specific Aims are to: 1) Establish a Community Action Board to advise on
ADRD outreach and AI/AN inclusion in research; 2) Expand the NEPC by enrolling AI/ANs into the IREACH
registry, including a subset with mild cognitive impairment and a subset with normal cognition into the UW ADRC
Clinical Core each year; 3) Conduct and evaluate outreach, engagement, and dissemination efforts that increase
AI/AN knowledge and awareness of ADRD and research opportunities; and 4) Interview AI/ANs enrolled in the
Clinical Core to assess experience in enrolling in an ADRD clinical trial; review toolkits and resources available
for recruiting participants into ADRD clinical trials; and determine strategies for communication about biomarkers
and return of results. This study promises to increase AI/AN representation in ADRD clinical studies, build trust
in research and researchers, and determine culturally appropriate methods to communicate about biomarkers
and genetic research. Through research on effective communication about biomarkers and return of results, we
will develop strategies to provide information on ADRD and genetic testing to AI/AN individuals and communities,
in alignment with NIH priorities to increase diversity in research participation, particularly ADRD clinical trials.